Drivers of the beneficial effects of influenza A virus co-infection

PROJECT SUMMARY/ABSTRACT
Influenza A viruses (IAVs) cause several million infections each year in the Unites States alone and have
significant health, economic, and ecological impacts, despite widespread pre-exposure, vaccination, and
surveillance efforts. Given the substantial, recurring impact of IAV on human health, it is essential to better
understand the fundamental processes shaping viral propagation. Throughout viral infection, the number of
virions infecting individual cells varies over space and time. Consequently, multiple infection is a common feature
of within-host viral expansion. For IAV, homologous cellular co-infection has the potential to increase viral
replication and progeny production, suggesting that multiple infection increases the chances of completing the
infection cycle successfully. This dynamic, in which groups of viruses are more often successful than single
viruses, is in line with the ecological concept of positive density-dependence. However, the specific viral
processes that give rise to these beneficial effects of multiple infection are unknown. Therefore, I hypothesize
that IAVs exhibit positive density-dependence during essential steps of the early viral life cycle and that
this dependence is heightened under an antiviral state. To test this hypothesis, I will use influenza
A/Netherlands/602/2009 (H1N1) virus (NL/09) to generate a panel of viral variants that are deficient in core
processes of the early viral life cycle and determine the extent to which the fitness effects of the introduced
mutations vary with multiple infection. In addition to being is a well-studied virus, NL/09 exhibits an intrinsically
low reliance on multiple infection. Using this virus will allow us to identify positive density-dependent phenotypes
conferred by the introduced mutations. In Aim 1, I will evaluate the density-dependence of discrete viral functions
by defining the relationships between viral density and the fitness effects of mutations that target those functions.
Each mutational fitness effect will be evaluated using the Lowen lab’s VAR1-VAR2 system, which comprises two
viruses differing by a single synonymous mutation introduced into each gene segment of the VAR2 virus. These
synonymous mutations allow measurement of the benefit of multiple infection on the replication of the focal virus.
In Aim 2, I will use viral genetic barcodes to investigate how the density-dependence of specific viral processes
interfaces with the replicative success rate of incoming viral genomes. Each variant virus will possess a distinct
barcode region in the neuraminidase (NA) segment with twelve bi-allelic sites, resulting in a total of 4096 unique
genotypes. I will utilize genetic barcodes to monitor the fate of individual barcodes within the population and to
detect changes in replicative success rate within a given cell and the viral progeny produced. For both aims, I
will further examine positive density-dependent phenotypes under an induced antiviral state. The findings of this
project will strengthen our fundamental understanding of the impact of multiple infection among IAVs, while
elucidating potentially important and underappreciated determinants of infection outcomes. This knowledge can
contribute to the development of improved infection control and mitigation strategies.

Public health relevance
PROJECT NARRATIVE Influenza A viruses infect a broad range of host species, resulting in significant and persistent health, economic, and ecological burdens worldwide. Currently, there is limited understanding of the mechanisms that facilitate successful infection within an individual host. This research aims to address this knowledge gap with the goal of improving infection control and mitigation strategies.